SC COBRE for Translational Research Improving Musculoskeletal Health (SC-TRIMH)

Registration of Smart Needle Measurements with Functional Ultrasonography by Machine Learning for
Quantitative Monitoring and Assessment of Myofascial Pain
Summary
This Team Science Development Project complements and extends the scope and objective of the on-going
COBRE project entitled “South Carolina COBRE for Translational Research Improving Musculoskeletal Health
(SC-TRIMH, P20GM121342). The goal of SC-TRIMH is to enhance and expand the Biomedical Research
capacity at Clemson University and the State of South Carolina to promote outstanding multidisciplinary,
collaborative, and translational research in bone and joint diseases. SC-TRIMH proposes to implement a novel
scientific concept for translational research, i.e., Virtual Human Trials, through powerful computational modeling
combined with quantitative functional validation and assessment to expedite the process from concept
development to deliverable new therapeutics, interventions, and devices for musculoskeletal health. The specific
aims of SC-TRIMH are to: 1) train and mentor an initial cadre of five targeted junior investigators; 2) develop and
enhance key areas of research infrastructure through the development of novel cores; and 3) promote the long-
term viability of SC-TRIMH through technology transfer and rigorous evaluation and improvement strategies.
The scientific cores of SC-TRIMH include: 1) Multi-scale Computational Modeling Core; 2) Advanced Fabrication
and Testing Core; and 3) Preclinical Assessment Core. These cores provide key technical support to the junior
investigators to implement the new concept of Virtual Human Trials to advance musculoskeletal health and
facilitate their competitiveness for national research awards.
Chronic musculoskeletal pain is estimated to affect 10% - 20% of the general population and has been a
major public health problem. Among patients presenting with chronic musculoskeletal pain, the prevalence of
myofascial pain syndrome (MPS) can be as high as 85%. While MPS is believed to be related to the dysfunction
of myofascial tissues, however, currently there are no quantitative biomarkers that can quantify myofascial tissue
abnormalities in latent or active states of pain to differentiate them from the healthy state. Opioids are commonly
used to treat myofascial pain disorders with limited effectiveness but detrimental consequences. To improve
treatment of MPS and prevent opioid misuse, there is an urgent need to develop clinically effective quantitative
MPS biomarkers for effective management of chronic myofascial pain.
The goal of the proposed research is to develop an innovative machine learning (ML) generated biomarker
for quantitative assessment and differentiation of abnormal myofascial tissues in latent and active myofascial
pain stages from healthy tissues, to objectively monitor and assess the responses to myofascial pain treatment
and management. The new quantitative biomarker is enabled by innovatively integrating, through ML models,
the functional ultrasonography with novel microsensor-embedded smart needle measurements of the tissue.
The hypothesis is that the sensitivity and specificity of the ultrasound imaging diagnostics can be significantly
improved by adding accurate anchor point information (e.g., depth-resolved tissue stiffness and oxygenation via
a smart needle) to functional ultrasonography such as elastography (muscle stiffness) and Doppler ultrasound
(blood flow), through the developed ML models. The improved sensitivity and specificity will allow quantitative
structural and functional measurements of the myofascial tissue for better diagnosis and management of MPS.
The specific aims are: 1) develop smart needles for minimally invasive measurements of depth-resolved
myofascial tissue stiffness and oxygenation and co-register the results with ultrasonography; and 2) develop
quantitative metrics from multimodal functional ultrasonography and co-registered smart needle measurements
of myofascial tissues.
The Team Science Development project will be performed by an interdisciplinary team of engineers, data
scientists and physicians with combined expertise in sensor, instrumentation, manufacturing, computing,
machine learning, ultrasonography, sports medicine and pain management, and acupuncture. The collaborative
team science approach allows us to apply the latest data science method and cutting-edge sensor technologies
to addressing the fundamental challenges in pain management. The developed quantitative biomarker is
expected to become a new tool for enhancing the diagnosis, assessment, and effective management of MPS
via non-opioid therapies and non-pharmacologic treatments, and thus contributes to the NIH HEAL Initiative to
1) improve treatment and prevention of opioid misuse and opioid use disorder and 2) enhance pain management.
The initial studies and teaming resulted from this Team Science Development project will lay a solid foundation
for preparation and submission of research proposals.

Public health relevance
This study will assist the nation’s efforts to combat pain by using non-opioid strategies. The research team will collect biomarkers of myofascial pain from volunteers. Data collected by ultrasound and newly developed smart needle technologies will be used in machine learning studies that will assist the clinical acupuncturist to quantitatively measure and convey to patients the progress of pain mitigation and relief. These studies will enable us to design a therapeutic assessment tool for myofascial pain management.